In vivo real-time monitoring of reactive oxygen species and opioid signaling in a model for opioid receptor activity.

ABSTRACT
In 2017 the U.S. Department of Health and Human Services declared the ongoing opioid epidemic a public
health crisis after more than 47,000 Americans died from opioid overdoses during that year. A critical part of the
solution is to understand the fundamental reaction and adaptation of brain circuits to stimulation by opioids. For
example, the desensitization of opioid receptors is a critical problem in pain management because it requires
increasing doses of analgesic compounds, which could contribute to developing a drug addiction. Recently, it
has been shown that the activation of mu and kappa opioid receptors in neurons cause the production of reactive
oxygen species (ROS) through a pathway involving NADPH oxidase and c-Jun N-terminal kinase. Therefore,
this distinct response, downstream from the receptor, could be utilized to detect specific opioid receptor activation
and modulation. Current studies of opioid receptors rely either on in vitro experiments in cell cultures or analysis
of ex-vivo brain tissue to monitor them under drug exposure. We currently lack sensitive fluorescent sensors,
which would allow us to utilize state-of-the-art fiber photometry to directly monitor mu-opioid receptor (MOR)
activity in real-time and in vivo. Current limitations of contemporary sensors are slow response times, low
specificity, low signal output, toxicity, or dependency on ex vivo tissue preparation. Our goal is to develop a
genetically encoded sensor protein that detects ROS levels at endogenous levels with response time
and signal amplitudes that will enable in vivo monitoring of neuronal systems upon MOR activation. We
have recently developed a novel fluorescent ROS sensor by fusing a green fluorescent protein to a bacterial
hydrogen peroxide binding protein. Signal kinetics, ROS sensitivity, and signal amplitudes are significantly
enhanced compared to other available tools. We hypothesize that we can further increase the fidelity of this tool
by additional structure-guided protein design at the hydrogen-peroxide binding site and the interface between
the green fluorescent reporter and the sensing domain. Our objective is to express this novel tool in vivo in MOR
positive neurons and to link ROS signals to MOR activity pharmacologically. We hypothesize that ROS signals
in MOR neurons will increase under drug exposure. Second, we hypothesize that we will observe a decrease of
ROS transients under repeated drug exposure reflecting the desensitization of MORs. At the end of this project,
we will have a novel and highly specific sensor for monitoring opioid receptor activity and adaptivity. Our
proposal is significant because, for the first time, we will be able to monitor the adaptation of this clinically
relevant signaling pathway to opioid exposure in vivo. Our approach is innovative because we combine
structure-guided protein engineering and in vivo monitoring of opioid-triggered signals to dissect a difficult-to-
access neuronal signaling pathway. Furthermore, this approach could be broadly applied in future studies to
monitor the activity levels of opioid receptors during drug exposure and link the subsequent changes in neuronal
signaling and plasticity to motivated behaviors, or analgesic tolerance.

Public health relevance
PROJECT NARRATIVE A critical part of resolving the ongoing opioid crisis is to understand the fundamental physiological reaction of the brain to drug exposure. We propose to develop a fluorescent sensor that precisely monitors the activity level of opioid receptors in response to drug exposure, in real-time and in vivo, in neurons of rodent models. We aim to utilize the sensor to study a potentially clinically relevant mechanism that controls the development of drug tolerance in the brain to verify the broad applicability of our sensor.